CONTROL OF LUTEAL FUNCTION AND INDUCTION OF OVULATION AND CONCEPTION

This project is designed to study the effect of two treatment regimens using hormone stimulants to induce ovulation and conception in bitches. The major areas of interest are: 1) the induction of regression of the functional corpora lutea by hormone administrative; and 2) the induction of follicular development and ovulation followed by breeding bitches pretreated with hormone to regress corpora lutea.